HISTOPATHOLOGY OF PARS PLANITIS AND EXPERIMENTAL AUTOIMMUNE UVEITIS

Studies in animals and in patients are being carried out to determine factors influencing ocular immune responses. In an animal model, rats are immunized with S-retinal antigen to produce experimental autoimmune uveitis. Animals in one group received anti-Ia antibody intraperitoneally and developed the onset of uveitis significantly later and to a lesser extent than controls. Histopathologically, the anti-Ia treated animals had much less inflammation than did controls. A human eye with pars planitis was also studied immunohistologically. In the pars plana region there was an elevated helper to suppressor T-cell ratio. In addition, the snowbank area showed staining for glial fibrillary acid protein Muller cells, type IV collagen and laminin. There was staining for HLA-DR throughout the globe. The results of these studies shed light on how surface antigens effect and are transmitted by ocular immune responses.